Control of cell ratcheting engagement during epithelial morphogenesis

Project Summary
Force generation in epithelial tissues is often pulsatile, with actomyosin networks generating high-tension
contractile forces at the cell cortex before cyclically disassembling. This pulsed nature of cytoskeletal forces
implies that there must be cellular processes to extract unidirectional changes that drive processive
transformations in cell shape. In previous work (Jewett et al., 2017; Miao et al., 2019), we found that
cytoskeletal force generation is coordinated with endocytic remodeling of the plasma membrane through Sbf-
Rab35 tubular compartmental function to stabilize contracted cell surfaces and permit the shrinking of cell
apices (apical constriction) or cell interfaces (cell intercalation). However, how this membranous cellular
ratchet becomes engaged at particular cell surfaces remains unclear. In the proposed studies, we will
examine the informational signals that engage ratcheting and direct Sbf/Rab35 compartmental behaviors to
contracting interfaces or cell apices, and identify the fundamental changes in oscillatory durations, amplitudes,
frequencies, and/or directionality that lead to contractile processivity. Our preliminary data indicates the PIP3 is
a critical determinant for ratcheting engagement – through our proposed work we will perform the first
characterization of phosphatidylinositol phosphates (PIPs) in providing lipid-based membrane cues for
morphogenesis and gastrulation/ratcheting dynamics in the early Drosophila embryo. In the first aim, we will
also analyze how the plasma membrane ultrastructure is remodeled by ratcheting processes and determine if
PIP levels are developmentally patterned to drive apical constriction during mesoderm ingression. Our project
then moves to a systematic identification of Sbf and Rab35 protein partners in directing ratcheting
engagement, and examines the cell signaling pathways that direct a “switching” behavior of contractile force
generation from the apical surface to cell interfaces. Our data indicates that, in the absence of JAK/STAT
signaling, the Sbf-Rab35 ratchet becomes engaged on all apical surfaces in the embryo, resulting in global
apical flattening and constriction. Further, our studies will define if a larger Upd-JAK-STAT-Pi3K-PIP3-Sbf-
Rab35 pathway or if two independent pathways (PIP3 and JAK/STAT) have been coordinated to regulate
ratcheting engagement. We also apply a new computational phase-based osculating circle approach to detect
active periods of contraction and expansion displacements. Finally, we are developing a new mito-tag ectopic
relocalization assay as a measure of “sufficiency” of recruiting factors in vivo, and examine if the Akt/mTOR
pathway regulates cell ratcheting, potentially demonstrating a new, highly novel function of Akt/mTOR in
controlling epithelial cell topologies. Thus, the planned project has the potential to elucidate a large, regulatory
hierarchy of the mechanisms that guide engagement of cell ratcheting in epithelial tissues.

Public health relevance
Project Narrative In the course of development, epithelial tissues must be able to dynamically remodel their dimensions to generate adult tissue morphologies, as well as permit new cells to replace aging cells. The intention of the proposed study is to examine the processes that permit directed cell movements within an epithelial context. We are using a combination of computational and cell biological approaches to determine how membrane ratcheting mechanisms permit the processive contraction of individual cellular surfaces.